Characterizing Retinal Tissue Oxygenation, Structure, and Function in Alzheimer's Disease

Alzheimer’s disease (AD) is a progressive neurodegenerative disease affecting approximately 5.3 million
people in the US, and projected to reach 13.9 million by 2026. Progress in the management and treatment of
AD is limited by lack of early diagnostics, which are critical to the development of effective therapies. AD is
currently described in three stages; the preclinical, the mild cognitive impairment (MCI), and Alzheimer’s
dementia. The difficulty lies in detecting the disease during the preclinical phase, when patients show no
clinical symptoms of cognitive impairment but there is underlying pathology. Currently, we are limited to
detecting the accumulation of amyloid plaques in the brain using expensive and invasive methods such as
Positron Emission Tomography and cerebrospinal fluid assessment via lumbar puncture. The goal of this
proposal is to develop a novel, non-invasive, and cost-effective retinal vascular biomarker for early AD risk
detection and disease monitoring. There is increasing evidence that there are retinal manifestations of AD; the
neurodegeneration in the brain of AD patients has been shown to be associated with reduced retinal nerve
fiber layer (RNFL) and retinal ganglion cell (RGC) layer thickness. Thus, the human retina is an easy to
examine part of the brain providing an opportunity to study and to possibly detect AD early. There is
breakdown of the inner retinal blood barrier, pericyte loss, and capillary non-perfusion or dropout in AD. We
have previously characterized metrics of retinal tissue oxygenation in the form of periarteriole and perivenule
capillary free zones (peripheral CFZs). Building on these prior results, our central hypothesis is that the CFZ
will be enlarged in older cognitively unimpaired (CU) participants at high risk for AD, MCI, and mild AD
patients, and this will be associated with reduced RNFL and RGC layer thickness, reduced field of vision, and
reduced sensitivity to contrast. We will test our central hypothesis by completing the following aims: AIM 1:
Quantify and evaluate differences in the peripheral CFZ, structural, and functional measures between
low-risk CU older adults, high-risk CU older adults, MCI, and mild AD groups. We will collect high quality
optical coherence tomography angiography images, structural, and functional measures in the 4 groups with
data from the low-risk CU participants serving as baseline or control data. We will compare the CFZ, structural,
and functional measures in the 4 groups of participants using analysis of covariance. AIM 2: Identify
associations between the peripheral CFZ, structural, and functional measures in high-risk CU, MCI, and
mild AD groups. We will use multiple linear regression models to test the associations of the CFZ versus
structural and functional parameters. Outputs from this proposal will identify whether CFZ measures can be
used as a potential retinal biomarker of early AD risk detection and disease monitoring. Results from our
studies will advance both the NIA’s goal of understanding the nature of biomedical changes associated with
AD and the goal of the National Alzheimer’s Plan to prevent and effectively treat AD by 2025.

Public health relevance
Project Narrative In order to advance our understanding of the nature of biomedical changes associated with Alzheimer’s disease (AD), we will develop a novel, non-invasive, and cost-effective retinal vascular biomarker for early AD risk detection and disease monitoring. An understanding of metrics of retinal tissue oxygenation and their associations with retinal structure and other functional measures in AD patients will provide information valuable for the early detection, management, and monitoring of the disease in the preclinical phase. Outputs from this proposal will be used to identify whether a novel retinal vascular biomarker can be used to characterize distinct cognitive groups and thus identify it as a potential retinal biomarker of early AD risk detection and disease monitoring.